The Ikaros zinc finger transcription factor Eos as a candidate regulator of TH2 differentiation and effector function

PROJECT SUMMARY/ABSTRACT
To mount effective responses to specific pathogens, CD4+ T helper cells differentiate into specialized subsets
that can recognize and promote clearance of foreign pathogens. However, dysregulation of these CD4+ T helper
cells can lead to allergic and autoimmune conditions. One such subset is CD4+ T helper 2 (TH2) cells, which
normally target parasites but are often implicated in asthma, a hyperinflammatory airway disease. Therefore,
understanding the molecular mechanisms of TH2 cell regulation is a top priority for improving outcomes for
asthma and other hyperinflammatory conditions. To this end, we have identified the Ikaros Zinc Finger (IkZF)
transcription factor Eos as a candidate regulator of TH2 differentiation and function. Published work has largely
associated Eos with immunosuppressive regulatory T cells. However, our data demonstrate a novel mechanism
by which Eos propagates IL-2/STAT5 signaling within proinflammatory TH2 cells. Preliminary work from our lab
shows Eos-deficient TH2 cells generated in vitro or in an in vivo allergic asthma model have reduced gene and/or
protein expression of critical TH2 differentiation transcription factors (e.g. Gata3, Blimp-1), receptors (e.g. IL-2R⍺,
IL-4R⍺) and effector cytokines (e.g. IL-4, IL-13). Excitingly, in vitro and overexpression studies also reveal Eos
forms a novel complex with and promotes the tyrosine-phosphorylated activation of STAT5, suggesting a new
mechanism whereby Eos governs CD4+ T cell differentiation. Through the work in this proposal, we will determine
the T cell-intrinsic impacts of Eos on TH2 differentiation and define the molecular mechanisms by which Eos
regulates STAT5 phosphorylation and target gene binding to drive the TH2 gene program.
The proposed studies will be completed by the applicant, Jasmine Tuazon, an MD/PhD candidate in the
laboratory of the Sponsor, Dr. Ken Oestreich. Dr. Oestreich is an Associate Professor in the Department of
Microbial Infection and Immunity (MI&I) at The Ohio State University College of Medicine, which provides an
outstanding technical and intellectual immunology research environment. Additionally, Ms. Tuazon will be
mentored by a committee of immunology experts and collaborators, including Drs. Eugene Oltz (Chair, MI&I),
Kymberly Gowdy (Assoc. Prof., Division of Pulmonary, Critical Care, and Sleep Medicine), and Jerry Lio (Asst.
Prof., MI&I), who all provide strong, complementary expertise to Dr. Oestreich. Training will involve the
development of conceptual and technical expertise, including pulmonary murine models, cellular and molecular
immunology techniques, and integrated -omics approaches. Through this fellowship, Ms. Tuazon will also
receive excellent professional development training in scientific communication, writing, and networking.
Taken together, the proposed work will 1) provide novel mechanistic insight into the role of Eos in promoting
TH2 differentiation and function via IL-2/STAT5 and 2) advance Ms. Tuazon’s conceptual and technical expertise
as she pursues an independent physician-scientist research career in pulmonary immunology and epigenetics.

Public health relevance
PROJECT NARRATIVE: CD4+ T helper 2 (TH2) cells normally function against parasitic diseases but can largely contribute to the development of asthma, a hyperinflammatory airway disease with increasing prevalence worldwide. Gaps in knowledge exist regarding the mechanisms governing TH2 differentiation and effector function. The work described in this proposal seeks to provide novel mechanistic insight into the molecular regulation of TH2 cells, with an overarching goal to identify molecular targets that can be leveraged for therapeutic benefit.